Molecular Engineering of Novel Therapies to Treat Corneal Neovascularization

PROJECT SUMMARY:
The cornea is a unique structure that remarkably maintains its optic clarity by remaining completely
avascular. Diseases in which the optical clarity of the cornea is lost are the third most common cause of
blindness worldwide. Although the etiology of these diseases may be distinct, most converge on a common
pathway leading to the growth of pathological vessels in this tissue, a process known as corneal
neovascularization (CoNV). CoNV is ultimately a consequence of an imbalance between proangiogenic factors
and antiangiogenic factors in the corneal limbus. As vascular and lymphatic vessels grow into the corneal
stroma, edema, inflammation, protein and lipid deposition, and scarring can occur, leading to corneal opacities,
visual impairment or blindness. It is estimated that 1.4 million people develop CoNV per year, 12% of whom
suffer the subsequent significant loss of vision.
We have recently described the role of Angiopoeitin-like 4 (ANGPTL4), as a potent pro-angiogenic and
vessel hyperpermeability factor in posterior segment diseases, including diabetic retinopathy, proliferative
sickle retinopathy, and uveal melanoma. Interestingly, we recently found an additive effect in the induction of
vessel hyperpermeability by ANGPTL4 and VEGFA. Furthermore, we found that ANGPTL4 binds Neuropilin
(NRP)1 and 2, two plasma membrane isoforms that act as co-receptors for several members of the VEGF
family. More recently, we have observed a role for ANGPTL4 in promoting angiogenesis in the anterior
segment, leading to the development of CoNV and corneal pterygia. Growing appreciation of the role of
lymphangiogenesis in the development of anterior segment pathological angiogenesis prompted us to explore
a role for ANGPTL4 in this process. Recently, we have observed that ANGPTL4 potently induces the migration
and sprouting of lymphatic endothelial cells (lECs), and this appears to be dependent on ANGPTL4 binding to
NRP2. Collectively, these observations suggest that ANGPTL4 could play a central role in the development of
CoNV. We propose that a combinatorial therapy targeting VEGFs and ANGPTL4 may be a more effective
treatment for CoNV patients.
The objective of this proposal is to investigate the role of ANGPTL4/NRPs alone or in combination with
VEGFs as regulators of hemangiogenesis and lymphangionesis and thus as important pathways influencing
the avascularity of the cornea. The successful completion of these investigations will move us towards a
combinational therapy targeting ANGPTL4 and VEGF signaling as a novel alternative for the treatment of
CoNV.

Public health relevance
NARRATIVE: Corneal neovascularization (CoNV) is a sight-threatening condition affecting more than 1.4 million people per year. The objective of this proposal is to investigate the role of Angiopoietin- like 4/Neuropilins, alone or in combination with VEGFs, as regulators of hemangiogenesis and lymphangiogenesis in CoNV. The ultimate goal of our investigations is to design better therapeutic modalities for the prevention and treatment of this blinding disease.